Alliance to Disseminate Addiction Prevention and Treatment (ADAPT): A Statewide Learning Health System to Reduce Substance Use among Justice-Involved Youth in Rural Communities.

PROJECT SUMMARY
Indiana ranks 13th nationally in drug overdose deaths and Hoosiers at risk for opioid misuse and other
substance use disorders (SUDs) are unlikely to receive necessary services; Indiana - a largely rural state -
ranks 46th in number of behavioral health treatment providers per individuals suffering addictions. By targeting
rural counties in a Midwest state, our research team seeks to address the national opioid crisis at its epicenter.
We will also focus on a population among those at greatest risk for opioid-related harms: youth involved in the
juvenile justice system (YJJ). Among arrested youth, 78% have recently used illicit substances. Our research
has shown that YJJ die at 1.5 times the rate of youth who have never been arrested, and a leading cause of
YJJ death is drug overdose. The primary goal of our proposed project, Alliances to Disseminate Addiction
Prevention and Treatment (ADAPT), is to address barriers to effective SUDs treatment of YJJ as identified by
the substance use care cascade. We will accomplish our goal by creating a Learning Health (LHS) alliance
between the juvenile justice system (JJ) and community mental health centers (CMHCs) in 8 rural Indiana
counties. These collaborative JJ-CMHC partnerships will facilitate SUD risk identification and service
connection by JJ and enable timely initiation and engagement in evidence-based SUD treatment provided by
CMHCs. We have employed a LHS alliance model to develop alliances between JJ and CMHCs. We have
maximized opioid use prevention efforts by implementing a bundled treatment approach to improve screening,
resource allocation, workforce development and evidence-based interventions (EBIs) that target a range of
SUD risk levels. We hypothesize that ADAPT – a combination of the LHS alliances and dissemination of
targeted SUD EBIs – will positively affect SUD and recidivism outcomes over time. We will begin our
evaluation of this intervention. Thus, the goal of this supplement is to gather cost data on the LHS and EBI
expansion. We will be evaluating the benefit of ADAPT by completing the main aims of this project. By
gathering cost data, we will also be able to evaluate the cost effectiveness of this model and evaluate the
implementation costs. We will utilize our expertise in implementation science, community-based research,
clinical trials, cost-effectiveness research, and linking administrative databases, for research to assess the
impact of these interventions on criminal recidivism and substance use outcomes, including transition to opiate
use disorders and opiate overdose. By incorporating cost effectiveness and implementation models into this
work, we will be well poised to sustain this intervention and expand it to additional jurisdictions.

Public health relevance
Through this project, we seek to improve collaboration between juvenile justice settings and community mental health centers. We will test the impact of a Learning Health System Alliance focused on continuous quality improvement and training in evidence‐based intervention. This supplement is focused on gathering relevant cost effectiveness and implementation data to evaluating the benefit of this work based on costs.